Do discrimination and adversity drive the inflammatory basis of suicidal ideation in Black and Latinx young adults?

PROJECT SUMMARY/ABSTRACT
In recent years, the prevalence of suicidal ideation among young Black and Latinx individuals has been on the
rise1,2,3 with racial/ethnic discrimination and adverse childhood events (ACEs)4,5 thought to explain this health
disparity. Systemic inflammation—a product of over-activation of the body’s stress response system—has
been hypothesized to play a unique predictive role in suicidal ideation development6,7,8. Experiencing
racial/ethnic discrimination and ACEs can lead to systemic inflammation9,10,11—possibly accounting for suicidal
ideation’s growing prevalence among young racial/ethnic minorities who experience ACEs and discrimination
at disproportionate rates. Conversely, secure attachment relationships have been associated with a reduction
in systemic inflammation12 and a lower risk for suicidal ideation13. The broad aim of this fellowship research
is to test biological and relational mechanisms explaining suicidal ideation among racial/ethnic
minority young adults, specifically examining ACEs and racial/ethnic discrimination as risk factors as
well as the mediating role of systemic inflammation and the protective effects of close relationships.
Chronic exposure to racial/ethnic discrimination and ACEs can lead to dysregulation of the hypothalamic-
pituitary-adrenal (HPA) axis, leading to an exhausted release of proinflammatory cytokines and systemic
inflammation10,14,15. Biological models identify systemic inflammation as a potential mediator of suicidal ideation
given elevated levels of proinflammatory cytokines in individuals with suicidal behaviors6,8,9 Further, studies
have shown ACEs and racial/ethnic discrimination can alter proinflammatory cytokine levels and signaling10,15
However, no study has attempted to investigate systemic inflammation as a mediator of suicidal ideation in
adulthood nor the proposed risk or protective factors within this pathway. This proposal addresses these gaps
by (a) examining whether the links between ACEs and racial/ethnic discrimination with suicidal ideation are
mediated by systemic inflammation and (b) examining attachment security as a moderator. This proposal
utilizes a biopsychosocial model integrating multiple levels of analysis (i.e., immunobiological, behavioral,
relational). It reflects the mission of the National Institute of Minority Health and Health Disparities (NIMHD) to
identify mechanisms and protective factors of disparities such that this study aims to elucidate how
systemic inflammation might arise from ACEs and racial/ethnic discrimination and increase risk for
suicidal ideation in young adults with emphasis on the protective effects of secure attachment
relationships to uncover fundamental mechanisms of a pressing health disparity in diverse
populations. Finally, this award will aid in training a young researcher seeking to understand the mechanisms
associated with negative outcomes in young adults from ethnic/racial minority groups by providing necessary
scaffolding toward an independent research career and opportunities for advanced research skills breadth
depth of knowledge across disciplines.

Public health relevance
PROJECT NARRATIVE Minority mental health is a serious public health concern, and a growing body of literature demonstrates important negative mental health effects, like suicidal ideation, disproportionately affecting Black and Latinx young adults and arising from systemic inflammation. Therefore, utilizing a biopsychosocial model and cutting across multiple levels of analysis (i.e., immunobiological, behavioral, relational) the proposed study will be the first to examine immunobiological and relational mechanisms associated by which ACEs and racial/ethnic discrimination among minority young adults confer risk for suicidal ideation. As the first study to examine relations among systemic inflammation, suicidal ideation, ACEs, racial/ethnic discrimination, and secure attachment, the proposed research seeks to elucidate the fundamental mechanisms (e.g., immunobiological, relational) by which suicidal ideation develops in minority young adults and identify protective factors to be leveraged in treatment.